Cancer Research Training and Education Coordination

9.0 Abstract: Cancer Research Career Enhancement and Related Activities
Education and training of next-generation cancer researchers is essential to continue the top-quality basic,
translational, clinical, and prevention research required to control cancer in Maryland and around the world.
Cancer Research Career Enhancement and Related Activities (CRCERA) at the University of Maryland
Marlene and Stuart Greenebaum Comprehensive Cancer Center (UMGCCC) include cancer education,
research training, career development, and continuing education programs that stream through our community,
from middle school through postdoctoral education. Cancer education and research training are integrated
seamlessly across UMGCCC basic and translational research, and the clinical activities. Educational and career
advancement activities are leveraged across the pipeline programs and with partners in our surrounding
catchment area, the University of Maryland–College Park, the University of Maryland–Baltimore County, Towson
University, and Morgan State University. CRCERA are coordinated by the UMGCCC Training and Education
Steering Committee, which is chaired by the associate director of Training and Education and is composed of
UMGCCC senior leadership, directors of formal education and training programs, and education partners in the
participating schools of the University of Maryland–Baltimore (UMB). During the previous funding period, the
cancer training programs provided research experiences and career development opportunities for more than
730 students across the training and education continuum. These programs are supported by 17 National
Institutes of Health grants; 3 additional cancer-focused or cancer-related institutional training grants, including 2
grants from the National Cancer Institute; and several individual fellowships. CRCERA are expanding to support
the goals of inspiring, educating, training, and developing the careers of the next generation of cancer
researchers from diverse backgrounds and multiple disciplines. UMGCCC will achieve this goal through three
specific aims: (a) coordinate and support innovative research programs and transformative experiences that
encourage students to explore careers in cancer research and that will enhance UMGCCC research, clinical
activities, and community outreach; (b) expand infrastructure and analytical tools for assessing metrics and
outcomes of existing and developing CRCERA to provide the most effective programs possible; and (c) build on
diversity-focused, early pipeline programs by expanding partnerships with minority institutions and enhancing
stakeholder connections throughout the catchment area to encourage talented, underrepresented students to
pursue careers in cancer research and clinical care. UMGCCC programs, faculty and administrative staff, and
shared services support these aims.